Mechanism of touch sensitivity in rapidly-adapting mechanosensory corpuscles

The ability to sense the world though physical contact is essential for all living organisms. In vertebrates, transient
touch and vibration are detected by Pacinian corpuscles, but the mechanism of their function is poorly
understood. Pacinian corpuscles are innervated by rapidly-adapting mechanoreceptor afferents, which detect
touch due to expression of mechanically activated ion channels. The mechanoreceptor is surrounded by inner
core cells, which are thought to provide auxiliary non-sensory support for the mechanoreceptor. Here, we will
functionally test the hypothesis that inner core cells of Pacinian corpuscles are active touch sensors. We seek
to reveal the molecular mechanism of touch sensitivity and touch-evoked excitability in inner core cells, and
determine the effect of inner core cell activation on mechanoreceptor function. To do this, we will use bill skin of
tactile specialist ducks, which contains a high density of Pacinian corpuscles accessible for electrophysiological
manipulations. Because Pacinian corpuscles are present in the skin or internal organs of most vertebrates,
including all mammals, our results will further our understanding of general molecular and cellular mechanisms
of touch detection.

Public health relevance
Mechanosensitivity is a fundamental physiological capacity which allows us to interact with the environment through the perception of mechanical force, but molecular and cellular mechanisms that contribute to the modulation of mechanotransduction and mechanosensitivity under normal, pathological or adaptive conditions remain to be fully elucidated. The objective of this proposal is to elucidate how mechanical force is perceived at the molecular level in rapidly-adapting mechanoreceptors. Insights gleaned from these studies will facilitate the development of pharmacological strategies to treat a range of neurological disorders associated with altered mechanosensitivity in humans.